Increasing the Power and Generalizability of Late-Talker Prediction: An Integrative Data Analysis Approach

PROJECT SUMMARY
The inability to meet developmental language milestones, known as late-talking or late-language emergence, is
associated with developmental delays and deficits in a variety of academic, social, emotional, and other
developmental skills. Current research in the field has identified some predictors of late-talking and subsequent
language skills, but findings have generally lacked consistency, and issues with lack of statistical power,
inconsistent measure use, and more have significantly limited the generalizability and reliability of these findings.
The current project aims to address these issues through three steps. First, we aim to increase the availability
of data on late-talkers that are available to researchers in the area. This will be done by curating and ingesting
extant datasets on late-talkers into a learning and development domain-specific data repository known as
LDBase. Making these data available to the public will increase the reach of each individual dataset, connect
researchers with differing backgrounds and expertise to the datasets, and lead to more efficient use of the
collected data. Second, we plan to integrate the contributing datasets using integrative data analysis (IDA),
integrating the datasets by applying IDA to create a new consistently scaled language measure across the
datasets. This serves to provide a dataset that addresses the issues of statistical power and inconsistent
measure use. This also will provide the opportunity for new questions to be answered via the ability to analyze
cross-study differences and the increased variance that exists in the bioecological factors assessed. Third, we
will highlight the potential of the newly integrated dataset by analyzing the dataset to explore current gaps in
knowledge related to the inconsistency of findings surrounding the bioecological factors that influence language
development and predict late-talking. Specifically, we will link the original data with consistently reported and
standardly measured GIS data describing the participants’ environments, and subsequently analyze how these
measures and the bioecological factors measured in the contributing datasets predict the newly integrated
language measure. This provides a more robust analysis of the prediction of the measure, given that the measure
is now consistently scaled and invariant across studies, ensuring that the same consistent construct is being
assessed and predicted across the various projects. We have leveraged our existing relationships with
researchers in the area to obtain commitments from 5 sites to share their data from 11 projects, representing
around 1,300 total individuals. We likewise will leverage our experience conducting similar studies and working
with collaborating sites to quickly and efficiently carry out this project in the given timeframe, a timeline we believe
would not be feasible for researchers without this direct experience. Finally, we will use this process to further
disseminate open-science materials and best-practice documents for data sharing that we have developed via
other NIH-funded initiatives.

Public health relevance
PROJECT NARRATIVE This project aims to increase the field’s knowledge base surrounding the bioecological factors that predict late- talking and delays in language development via the public upload of high-quality extant datasets, the integration of said datasets, linkage of original data with GIS data, and subsequent analysis of said integrated dataset. This project aims to address existing issues in this area of research by increasing the reach of individual datasets and increasing the statistical power and types of analyses available via the integrated dataset, specifically exploring the question of how environmental and bioecological factors differentially predict language skills. This project will also aim to exemplify and disseminate materials on best practices related to open-science and data sharing, providing a framework for performing these activities and connecting researchers with high-quality materials that have been developed via recent NIH-funded projects.